Behavior and Neuroimaging Core

Project Summary
The research projects proposed in the COBRE Center for Central Nervous System Function involve a wide
range of complex neuroimaging and non-invasive brain stimulation methods used both individually and in
multiple combinations. These methods include, but are not limited to, structural MRI, task-based and resting
state functional MRI, diffusion imaging, transcranial magnetic stimulation, transcranial direct-current and
alternating-current stimulation, galvanic skin response, electroencephalography, and eye tracking. The
complexity of these techniques and the challenges of mastering the infrastructure required to effectively and
efficiently deploy them can significantly impede research progress, especially in the case of relatively junior
investigators. The function of the the Behavior and Neuroimaging Core (BNC) is to provide ongoing expert
support, training, assistance and advice to the COBRE project leaders in the practical aspects of data
collection, data management and data processing related to these methods. The specific aims of the BNC are
(1) to provide support and assistance to COBRE Project Leaders and their research teams to promote and
facilitate the acquisition of high quality research data; and (2) to facilitate analysis of COBRE research data
through deployment of tools, analysis platforms, and training. To meet these aims, the Core will coordinate the
deployment and maintenance of shared research infrastructure to ensure that research equipment is functional
well documented. The Core will collect and evaluate quality assurance data to ensure that data collected are of
high quality and to identify and correct problems at an early stage. The Core will provide researcher training,
individually and in group settings, in order to promote the use of “best practices” when collecting data using a
variety of methods. It will provide expert consultation to Project Leaders to guide their choices regarding the
complex and interacting acquisition parameters that must be speciﬁed for various acquisition techniques.
Working with the Design and Analysis Core of this COBRE Center, the BNC staff will deploy and support new
analytical tools and platforms to ensure that researchers have access to state-of-the-art methods and tools for
processing their complex data sets. The BNC will create robust data processing pipelines for the analysis of
neuroscience research data that leverage the existing and growing computational infrastructure available at
Brown. The BNC will assist with data management to ensure that large research datasets are available when
needed and protected. In coordination with the Center for Computation and Visualization, the BNC will provide
training and support for the use of high-performance computing resources. By meeting these goals, the BNC
will (1) accelerate the pace of COBRE research, (2) establish supportive collaborative relationships among
COBRE investigators and between COBRE investigators and the local research community based on common
solutions to shared challenges, and (3) ensure the availability and accessibility of high quality physical and
computational research infrastructure to COBRE investigators and the broader local research community.